Molecular basis of adenosine transport and reuptake inhibition in human

Ischemia-reperfusion (IR) injury is a phenomenon in which hypoxic tissue undergoes prolonged damage after
the return of oxygenated blood, proving a prevalent clinical challenge faced in organ transplant, and ischemic
heart, lung and kidney diseases. Ultimately, IR injury can lead to increased infarct size, organ rejection and organ
failure. The purine nucleoside adenosine is produced extracellularly in response to IR injury, and elicits
cardioprotective, pulmonary protective and renal protective effects through agonizing adenosine G-protein
coupled receptors. However, the half-life of extracellular adenosine is extremely short-lived, as specialized
integral membrane transport proteins mediate the rapid membrane permeation of adenosine, where the
nucleoside is ultimately metabolized within the cytosol. Human equilibrative nucleoside transporters (hENTs) are
the main cellular adenosine transporters. Furthermore, adenosine reuptake inhibitors (AdoRIs), a chemically
diverse class of hENT inhibitors, potentiate extracellular adenosine signaling by preventing its rapid reuptake
through hENTs. Therefore, select AdoRIs are clinically used as vasoactive agents in the treatment of cardiopathy
and renal disorders. However, current AdoRIs are limited in their clinical effectiveness due to their poor
pharmacological properties and toxicities. Efforts to improve current AdoRIs or develop novel AdoRIs has been
challenged by the lack of atomic-level information on hENTs and the mechanism of AdoRIs. This proposed
research seeks to address this gap in knowledge by employing molecular, cellular, and chemical approaches to
interrogate features of adenosine reuptake inhibition, adenosine recognition and the transport mechanism
exhibited by hENTs. Notably, the rational design of novel adenosine reuptake inhibitors displaying improved
subtype specificity will be pursued using cardiac and renal model systems. This work will uncover the molecular
features of AdoRI activity, adenosine recognition, along with the transport mechanism exhibited by hENTs. In
total, successful completion of this work will provide the framework for improved pharmacological intervention of
adenosine biology, which will have far-reaching implications in the treatment of ischemic heart, lung, and kidney
disease.

Public health relevance
Relevance Ischemia-reperfusion (IR) injury presents a significant challenge in organ transplantation and in the treatment of ischemic heart, lung and kidney disease. There has been great interest in therapeutics targeting adenosine biology, as adenosine signaling stimulates cell protective effects that can mitigate the negative effects of IR injury, with the potential to improve patient survival outcomes in the clinic. Our proposal is focused on understanding the function and inhibition of an important human adenosine membrane transport protein, which will set the stage for the development of novel adenosine reuptake inhibitors purposed to combat IR injury in cardiac, pulmonary and renal disorders.